National Health and Nutrition Examination Survey 2021-2022, Liver Ultrasound Elastography with Liver Genetic Component.

National Health and Nutrition Examination Survey 2021-2022, Liver Ultrasound Elastography with Liver Genetic Component.